Suppression of MMP-13 Expression in Arthritis by Pomegranate

DESCRIPTION (provided by applicant): Osteoarthritis (OA) is the most common musculoskeletal disorder characterized by cartilage degradation and joint inflammation. Currently the only effective treatment is surgical joint replacement. MicroRNAs (miRNA) are a class of non-coding RNAs regulating gene expression by sequence specific inhibition of target mRNA translation. Specific miRNAs has been shown to exhibit altered pattern of expression in RA synovium and in other rheumatic diseases but their role in OA pathogenesis is yet to be defined. In our preliminary studies we analyzed the global expression of miRNAs in human chondrocytes stimulated with IL-12 and discovered that miRNA mir-27b (mir-27b), with no known function, was downregulated several fold. In silico analysis identified a number of possible target mRNAs including the matrix metalloproteinase-13 (MMP-13) mRNA. We have previously shown that a standardized pomegranate extract (PE) exert cartilage and chondroprotective effects by inhibiting the expression of MMP-13 in human cartilage explants in vitro and the development of inflammatory arthritis in a mouse model in vivo. Of relevance to the studies proposed in this application is our finding that downregulation of mir-27b by IL-12 was blocked by PE. Our basic hypothesis is that PE suppresses the IL-12-induced cartilage catabolic effects in OA by inhibiting the downregulation of mir-27b and other selected microRNAs that target MMP-13 mRNA in human chondrocytes. A corollary of this hypothesis is that bioactive constituents of PE exert their cartilage/ chondroprotective effects by modulating the expression of specific miRNAs that negatively regulate the expression of MMP-13 in vivo. We propose the following specific aims: Specific Aim- 1: We will identify other miRNAs that target MMP-13 mRNA in human chondrocytes and are differentially modulated by IL-12. Using a larger number of patient samples we will confirm the effect of IL-12 on the expression of mir-27b and other miRNAs identified above and determine whether PE prevents their modulation by IL-12 in human OA chondrocytes in vitro. Specific Aim-2: To determine the impact of altered expression of mir-27b and of other miRNAs identified above on the expression MMP-13 in human OA chondrocytes stimulated with IL-12 in vitro. Specific Aim-3: In a mouse model of OA we will develop the miRNA expression profile in the joints during disease induction and progression. We will also examine the effect of PE consumption on the expression of miR-27b and other miRNAs that target MMP-13 in mouse OA joints and correlate their expression profile with the disease progression. Knowledge gained from these studies may provide insight into developing novel and cost effective therapeutic approaches for the treatment/ prevention of OA.

Public health relevance
PUBLIC HEALTH RELEVANCE: Osteoarthritis (OA) is characterized by high levels of IL-12, excessive production of ROS and articular cartilage degeneration in the affected joints. However, its etiology and precise pathogenetic mechanisms remain unclear. MicroRNAs (miRNA) are a class of non-coding RNAs regulating gene expression by sequence-specific inhibition of target mRNA translation. Specific miRNAs have been shown to exhibit an altered pattern of expression in RA synovium and in other diseases. Currently there is limited information available on the expression of miRNAs in human chondrocytes but their role in OA is yet to be defined. In addition there is no information on the effects of dietary polyphenols on miRNA expression in any cell type. By studying the regulation of miRNA expression by bioavailable dietary constituents, our findings are likely to open the door for the development of novel therapeutic strategies for the treatment of OA and other diseases. ProgramDirector/Principal Investigator (Last, First, Middle): Haqqi, Tariq M. Public Health Relevance/Narrative Osteoarthritis (OA) is characterized by high high levels of IL-1β, excessive production of ROS and articular cartilage degeneration in the affected joints. However, its etiology and precise pathogenetic mechanisms remain unclear. MicroRNAs (miRNA) are a class of non-coding RNAs regulating gene expression by sequence-specific inhibition of target mRNA translation. Specific miRNAs have been shown to exhibit an altered pattern of expression in RA synovium and in other diseases. Currently there is limited information available on the expression of miRNAs in human chondrocytes but their role in OA is yet to be defined. In addition there is no information on the effects of dietary polyphenols on miRNA expression in any cell type. By studying the regulation of miRNA expression by bioavailable dietary constituents, our findings are likely to open the door for the development of novel therapeutic strategies for the treatment of OA and other diseases. PHS 398/2590 (Rev. 11/07) Page Continuation Format Page __SpecificAimsTextDelimiter__ A. Specific Aims Osteoarthritis (OA) is the most common musculoskeletal disorder characterized by cartilage degradation and joint inflammation. There are currently no diseases modifying treatments and the available therapies are mostly directed at symptom relief. In the absence of being able to modify structural progression of OA the only effective treatment is surgical joint replacement. The chondrocyte is the only cell type present in the cartilage and is activated by the inflammatory cytokines interleukin- 1β (IL-1β) and tumor necrosis factor-α (TNF-α) to produce matrix degrading molecules such as MMP- 13, ADAMTS-5, NO, and PGE2. We have recently shown that consumption of a standardized extract of pomegranate fruit (PE) suppresses the development of collagen induced arthritis (CIA) in mice-a model of human RA. Using an in vitro model of human cartilage degradation we have also shown that pomegranate extract exerts matrix and chondroprotective effects by suppressing the inflammatory cytokine IL-1β-induced expression of MMP-13 in human cartilage explants and chondrocytes. However, the precise molecular mechanism(s) of the cartilage and chondroprotective effect(s) exerted by PE or its bioavailable constituent polyphenols has not yet been elucidated. MicroRNAs (miRNA) are a class of non-coding RNAs regulating gene expression by sequence-specific inhibition of target mRNA translation. Evidence has emerged showing that in many instances some of the miRNAs target gene transcripts whose expression is associated with the inflammatory response including matrix metalloproteinase (MMPs), TNF-α, interleukin-6 (IL-6), as well as the signal transduction molecules (IRAK-1, TRAF6) required for the transmission of the inflammatory stimulus. Studies on the miRNA expression and function in human chondrocytes in vitro have just started to appear in the literature but their role in cartilage homeostasis or OA pathogenesis in vivo has not yet been reported. We have initiated studies in this regard and this proposal is based on our preliminary observation that compared to unstimulated human OA chondrocytes, miRNA miR-27b that targets MMP-13 mRNA and can repress its translation was severely down-regulated in human OA chondrocytes stimulated with IL-1β. We also discovered for the first time that IL-1β-induced down-regulation of miR-27b in human chondrocytes was inhibited by PE in vitro. Studies proposed in this application will test our hypothesis that "PE suppresses the IL-1β-induced cartilage catabolic effects in OA by inhibiting the downregulation and allowing for constitutive expression of miR-27b and of other selected microRNAs that target MMP-13 mRNA in human chondrocytes". A corollary of this hypothesis is that "bioactive constituents of PE exert their cartilage/ chondroprotective effects by modulating the expression of specific miRNAs that negatively regulate the expression of MMP-13 and of other catabolic factors in vivo" and thus might be helpful clinically. The following specific aims are proposed: Specific Aim-1: We will identify the complete repertoire of miRNAs that target MMP-13 mRNA in human chondrocytes and are differentially modulated by IL-1β. Using a sufficient number of patient samples we will confirm the effect of IL-1β on the expression of miR-27b and other miRNAs identified above and determine whether PE prevents their modulation by IL-1β in human OA chondrocytes in vitro. Specific Aim-2: To determine the impact of altered expression of miR-27b and of other miRNAs identified above that target MMP-13 mRNA on the expression of MMP-13 protein in human OA chondrocytes stimulated with IL-1β in vitro. Specific Aim-3: Using a mouse model of OA we will characterize the miRNA expression profile in the joints during disease induction and progression. We will also examine the effect of PE consumption on the expression of miR-27b and other miRNAs that target MMP-13 in mouse OA joints and correlate their expression profile with the disease progression in preparation for functional studies using identified miRNAs for chondroprotection. Our long term objective is to enhance the understanding of the molecular mechanism of action of dietary constituents in exerting chondroprotective and cartilage sparing effects. Knowledge regarding the modulation of specific miRNAs by dietary polyphenols may provide insight into developing novel and cost effective therapeutic approaches for the treatment/prevention of OA. 2